CIS RETINOATE+CISPLATIN &RADIOTHERAPY IN HEAD/ NECK CA

Compare at the completion of the followup phase the clinical and bacteriological relapse rates associated with two study regimens for pulmonary tuberculosis.